The role of limbal fibroblasts for the maintenance of limbal stem cells

Project Summary / Abstract
Corneal epithelium is maintained by stem cells residing in the limbus, the area between the cornea and
conjunctiva. These stem cells are known as limbal stem cells (LSCs) and give rise to progenitor cells, which
migrate toward central and apical cornea to form the stratified corneal epithelial cell layers. Loss of LSCs result
in limbal stem cell deficiency (LSCD), one of the most common causes of vision loss in the world. While
unilateral LSCD can be treated by transplantation of autologous limbal tissue, patients with bilateral LSCD
have to rely on allogeneic transplantation and the clinical outcome is relatively poor. In addition, there are
multiple post-operative complications reported including recurrent/persistent epithelial erosion, intraocular
pressure elevation, and rejection. Moreover, the shortage of corneal donors reduces the opportunity for
allogeneic transplantation. There is, therefore, a critical need to develop a less invasive therapy to treat LSCD
that also addresses the donor shortage. Besides the graft condition, it is important to control recipients’ limbal
niche microenvironment for a successful transplantation, since there has been growing awareness of the fact
that limbal niche cells play a critical role for the maintenance of LSCs. Of the niche cells, limbal fibroblasts are
thought to contribute to the maintenance of corneal epithelial phenotype by secreting fibroblast growth factor 7
(FGF7), whose secretion is promoted by platelet-derived growth factor (PDGF)-BB and interleukin 1 beta
(IL1β). However, it remains largely unknown how limbal fibroblasts are affected in the LSCD and how the
recovery of limbal fibroblasts contributes to the success of the treatment of LSCD.
Our long-term goal is to develop a novel treatment for LSCD by recovering the function of limbal niche.
Our overall objective in this proposal is to reveal the contribution of limbal fibroblasts in normal and LSCD
conditions, and to establish a limbal fibroblast transplantation technique. Our central hypothesis is that limbal
fibroblasts secrete FGF7 in response to PDGF and IL1β secreted by limbal dendritic cells to maintain the
limbal stem/progenitor cells. Moreover, we hypothesize that limbal niche including limbal fibroblasts are
disrupted in LSCD and transplantation of limbal fibroblasts regenerate the corneal phenotype in LSCD. In
addition to the human donor corneas, we will utilize a novel technique of eye-like organoid formation from
induced pluripotent stem cells (iPSCs) to create limbal fibroblasts as a cell source of transplantation to resolve
the corneal donor shortage. Proposed study will reveal the characteristics of limbal fibroblasts and limbal
dendritic cells (Aim 1), evaluate the interaction of limbal niche cells and limbal epithelial cells (Aim 2), and
establish limbal fibroblast transplantation for the treatment of LSCD (Aim 3). Successful completion of this
project will improve our understanding of limbal niche cells in normal and LSCD conditions, and provide us with
another strategic option to treat LSCD, namely limbal fibroblast transplantation. This will allow us to conduct
larger animal experiments and ultimately, apply this treatment to LSCD patients.

Public health relevance
Narrative Corneal epithelium is maintained by limbal stem cells and loss of limbal stem cells results in limbal stem cell deficiency, one of the most common causes of vision loss in the world. We propose to reveal the characteristics of limbal niche cells such as limbal fibroblasts and limbal dendritic cells, evaluate the interaction of limbal niche cells and limbal epithelial cells, and establish limbal fibroblast transplantation for the treatment of LSCD. Successful completion of this project will improve our understanding of limbal niche cells in normal and LSCD conditions, and provide us with novel strategic option to treat LSCD, namely limbal fibroblast transplantation.